Mass Cytometer CyTOF XT for Single-Cell Biology

PROJECT SUMMARY
Just within the past few years, there has been a remarkable progress in the field of single-cell and spatial biology,
illustrating the importance of understanding how particular cell types and cell states relate with one another. The
Mass Cytometry Facility at Johns Hopkins University (JHU), an operation within the Flow/Mass Cytometry
Shared Resource at the Sidney Kimmel Comprehensive Cancer Center (SKCCC), houses just one mass
cytometry platform, the Helios/Hyperion system, which switches between suspension and imaging modes. This
system is currently the only mass cytometry unit that is accessible by the Johns Hopkins community. Mass
cytometry overcomes any issues with fluorescence, such as cellular or tissue autofluorescence and spectral
spillover, allowing for the robust assessment of 40+ parameters at a per-cell basis. Since the establishment of
mass cytometry services in August 2021 made possible by the support of the Johns Hopkins Convergence
Institute and the JHU SKCCC, the usage of mass cytometry has been consistently increasing. With the recent
funding of major research activities by the NIH, the demand for mass cytometry services is expected to continue
growing dramatically, prompting this proposal for the funds to acquire a second mass cytometer in the form of
CyTOF XT, the latest generation mass cytometer, at our Mass Cytometry Facility. Mass cytometry will be
incorporated into the NIH-funded research activities led by more than 10 Major and 5 Minor Users across multiple
research programs and departments at Johns Hopkins, tackling important questions in pancreatic cancers, liver
cancers, breast cancers, computational biology, and dermatology. This unique discovery tool will also support
the research of several early-career investigators and other future users from the Johns Hopkins research
community at large. The successful implementation of a second mass cytometer will be facilitated by Dr. Won
Jin Ho’s (PI) expertise in mass cytometry techniques, experienced facility staff, existing infrastructure for the
system, and strong commitments from the School of Medicine, the SKCCC, the Convergence Institute, as well
as the Department of Cell Biology, the Department of Pathology, and the Division of Quantitative Sciences at
Johns Hopkins. This much needed expansion of mass cytometry services will sustain the prompt delivery of high
quality data to the researchers at Johns Hopkins and significantly accelerate the discovery process in biomedical
research.

Public health relevance
PROJECT NARRATIVE High-parameter cytometry and in-depth imaging analysis can yield critical insights into the complexities of biological processes, diseases, and treatments. By evaluating both suspended and tissue biospecimens with measurements of 40+ protein features at once with high customizability and in a relatively cost-effective manner, mass cytometry as a unique discovery platform has been significantly empowering multiple key research efforts at Johns Hopkins University. Leveraging the current infrastructure of Johns Hopkins Mass Cytometry Facility, this proposal seeks to fund a CyTOF XT as the second mass cytometer to meet the rapidly growing demands in a wide-breadth of NIH-funded research activities including multiple cancer research programs, bioengineering, computational biology, and dermatology at Johns Hopkins.